Progressive DNA Hypomethylation as a Measure of Mitotic History and Potential Contributor to Replicative Senescence.

PROJECT SUMMARY / ABSTRACT
Cellular and molecular alterations that accumulate during cell division are considered to be contributors to
aging phenotypes. Changes in epigenetic marks, including DNA methylation, have been widely documented in
aging. This has spurred the development of epigenetic molecular clocks, which rely primarily on replication-
independent gain of methylation at CpG islands. As molecular clocks tuned to chronological time across
different tissue types with varying mitotic rates and histories, these clocks are not directly linked to mitotic cell
division. In contrast, we have found that loss of DNA methylation at lamina-attached, late-replicating regions of
the genome is closely tied to apparent mitotic history. We propose to use primary human cell culture to
experimentally validate that mitosis is a driver of hypomethylation, and to explore the underlying mechanisms
and consequences of this hypomethylation, to define genomic and chromatin features driving hypomethylation,
and use this data to construct a mitotic molecular clock.
In Specific Aim 1 we propose to use primary human cell culture to provide experimental evidence for the
contribution of mitosis to PMD hypomethylation, and to disentangle the time-dependency and mitosis-
dependency of the phenomenon using cell cycle inhibition. We will also investigate whether enhancing
maintenance methylation machinery is able to counteract the progressive loss of DNA methylation. In Specific
Aim 2 we propose to investigate whether DNA hypomethylation contributes to replicative senescence or
associated phenotypes in primary human cell culture. We will investigate whether inhibition of maintenance
methylation accelerates senescence, and whether progressive hypomethylation is extended in telomerase-
immortalized primary human fibroblasts, contributing to premalignant phenotypes associated with such
immortalization. We will also investigate whether accelerated senescence by progerin expression or supra-
physiologic O2 leads to accelerated DNA hypomethylation. In Specific Aim 3 we will characterize the genomic
and chromatin features that influence individual CpG hypomethylation rates. We will measure the rates of DNA
hypomethylation of individual CpGs in six different primary human cell types and use this information to identify
cell-type-specific, as well as universal genomic and chromatin drivers of hypomethylation. Finally, we will use
elastic net regression on the assembled data to construct cell-type-specific and universal epigenetic mitotic
clocks in Specific Aim 4. The preliminary studies strongly support the concept and feasibility of a DNA
hypomethylation-based mitotic clock. The outcome of this proposed research could have important impacts on
our understanding of the contribution of widespread hypomethylation to aging phenotypes, with potential
implications for aging interventions. The availability of accurate molecular clocks specifically designed to
measure mitotic history would provide a valuable molecular tool to characterize cells and tissues in human
health and disease.

Public health relevance
PROJECT NARRATIVE Aging is a complex process involving many physiological, anatomic, metabolic, cellular, and molecular changes. We have identified a molecular change that appears to track the number of times that a cell lineage has divided. We propose to explore the mechanistic underpinnings of this process, and to develop this finding into a molecular clock.